Impact of homelessness and housing services on maternal and infant health

Project Summary/Abstract
Improving maternal, infant and child health and wellbeing (MCH) is an urgent public health priority. Birthing
people are experiencing increases in severe maternal morbidity (SMM) and other pregnancy-related health
conditions, while infant mortality in the first year of life remains greater in the U.S. than any other higher-
income country. There are substantial racial and ethnic inequities and disparities in MCH, which are strongly
influenced by social determinants. Thus, successfully advancing MCH in the U.S. requires interventions that
address underlying factors that affect health among disinvested communities, such as housing. Homelessness
is a growing phenomenon in the U.S. More than 1.2 million people experience homelessness each year, and
the number of people experiencing homelessness on a single night has been rising each year since 2016.
Women and girls are one of the fastest growing demographic groups among people experiencing
homelessness (PEH), and 4% of all birthing people experience homelessness in the year prior to delivery.
Health outcomes and behaviors associated with homelessness, such as lacking access to a regular source of
medical care, are known risk factors for pregnancy-related morbidity and adverse birth outcomes. Members of
racial and ethnic minoritized groups, who are more likely to face health-limiting systemic disadvantages, are
overrepresented among PEH, further exacerbating inequities in MCH. However, critical gaps in our
understanding of how homelessness affects MCH, and how evidence-based housing services affect MCH, limit
our ability to implement effective interventions. Our overall objective is to assess how and when the experience
of homelessness affects maternal and infant health and racial and ethnic health inequities, and whether
Permanent Supportive Housing (PSH) and Rapid Rehousing (RRH) interventions have a positive impact on
these outcomes. Our multidisciplinary team will apply quasi-experimental methods to linked administrative data
that include homeless and housing service information, Medicaid claims, all-payer hospital records, and birth
records. In Aim 1, we estimate effects of homelessness on maternal health conditions, health behaviors and
healthcare utilization during pregnancy. In Aim 2, we estimate effects of homelessness on postpartum maternal
and infant health and healthcare utilization. Our longitudinal dataset allows us to explore the timing of
exposure, account for preconception health and compare outcomes across different pregnancies for the same
person. In Aim 3, we estimate effects of PSH and RRH in this population. We use a difference-in-differences
framework to provide the first quantitative estimates of the impact of these interventions on maternal and infant
health and racial and ethnic health inequities. Guided by our advisory board members’ lived experience and
clinical training, findings will be used to develop intervention studies and inform policy to improve prenatal and
postpartum care for birthing people and infants who have experienced homelessness.

Public health relevance
Project Narrative This project investigates the effects of homelessness on maternal and infant health and assesses whether housing interventions can positively affect these outcomes and reduce inequities. We use linked administrative data and causal inference methods to explore how and when the experience of homelessness and the use of housing interventions affects health, health behaviors, and use of healthcare services during pregnancy and up to a year after birth. Findings will be shared with policymakers and health and homeless service system leaders and will be used to develop interventions that can mitigate the impacts of homelessness on maternal and infant health.